Mechanisms of behavior change in a genetics-informed smoking cessation intervention

PROJECT SUMMARY/ABSTRACT
Cigarette smoking remains the leading cause of preventable death. Several effective medications for smoking
cessation exist, but uptake of these treatments is low, making it difficult to quit smoking. Difficulty quitting
smoking is also driven in part by genetic factors, which have not been incorporated into cessation
interventions, marking a major scientific gap. Large genome-wide studies have shown that variation in nicotinic
receptor genes impacts the risk of smoking-related diseases and difficulty with quitting smoking. Incorporating
genetic information within a risk communication tool may engage current smokers in new quit attempts and
motivate treatment use. Genetically-informed interventions may promote cessation by changing health-related
cognitions (e.g., personalized benefits of treatment and cessation) and engagement (e.g., personal relevance
of the intervention). The overarching goal of this study is to advance the development of a genetically-informed
smoking cessation intervention—the RiskProfile—to lay the groundwork for a full-scale efficacy trial. This trial
will aim to test preliminary effects of the RiskProfile on medication use and smoking outcomes to estimate
effect sizes for a larger trial (Aim 1a), determine effects of the RiskProfile on potential change mechanisms
leading to smoking cessation (Aim 1b), and adapt the RiskProfile and evaluate feasibility and acceptability for
use in real-world community settings (Aim 2). For Aim 1, we will enroll 128 current smokers to receive genetic
testing, randomize participants to either the intervention (genetically-informed RiskProfile) or control (brief
cessation advice) group, and assess outcomes up to 6 months post-intervention. In this pilot, parallel-group,
randomized controlled trial (RCT), we will test effects of the RiskProfile on primary outcomes of use of smoking
cessation pharmacotherapy and average cigarettes smoked per day, and secondary outcomes of readiness to
quit smoking and biochemically-verified smoking abstinence. We will then test the effects on health-related
cognitions (perceived risk, benefits of treatment use and cessation, self-efficacy) and engagement (personal
relevance, comprehension, sharing results). In Aim 2, to explore the potential for transporting the RiskProfile
from research to community settings, we will conduct focus groups with individuals who smoke (n=20) and
substance abuse counselors (n=10) to adapt the tool for use in a partnering community health agency. Current
smokers and counselors (n=20 dyads) will then pilot test the RiskProfile protocol, and quantitative metrics will
be used to determine intervention acceptability and feasibility to proceed to a large-scale “real-world” efficacy
trial. If successful, this study will (1) incorporate novel genetic information in the development of a behavioral
intervention to promote medication use and smoking cessation, (2) reveal potential mechanisms of behavior
change to guide intervention adaptation, and (3) demonstrate the potential for translating precision discoveries
into efficacious tools to enhance the treatment of tobacco and substance use disorders more broadly.

Public health relevance
PROJECT NARRATIVE A person's genetics influence their smoking behaviors (e.g., how much they smoke, difficulty quitting) and risk of smoking-related diseases, yet these personalized factors have not been included in smoking cessation interventions. There is a need for tools that do consider these individualized factors to make them more personally engaging and thus motivating for treatment. This study will demonstrate feasibility of a larger trial to test the effect of a personalized genetics-informed intervention on smoking cessation.